Natural Product Inspired Novel Antimalarials with Radical Cure Potential

PROJECT SUMMARY/ABSTRACT
Despite the increased attention on the eradication of malaria, prevention and treatment of the disease remain
difficult due to i) the emerging resistance to the currently available antimalarials, including front-line artemisinin-
based combination therapy (ACT), ii) the absence of a clinically effective vaccine, and iii) the spread of
insecticide-resistant vectors. Therefore, there is an urgent and continuous need for safe, affordable and novel
antimalarial drugs that can combat multiple stages of the parasite life cycle, with novel mechanism(s) of action
to overcome the emerging drug resistance. We have developed a natural product inspired novel prodiginine
chemotype with broad-spectrum antimalarial activity. Our lead prodiginine candidate meets the aforementioned
key requirements, such as 1) novel chemotype; 2) equally effective against a large panel of blood stage
Plasmodium falciparum MDR parasites; 3) prevents liver stage infection with radical cure ability; 4) effective
against sexual blood stage P. falciparum gametocytes; 5) highly likely operates by a novel mechanism of
action; 6) optimal in vitro metabolic stability and in vivo PK profiles with rapid absorption, and long half-life; and
7) synthetically accessible with low-cost production. Our proposed work in this application seeks to develop a
novel antimalarial prodiginine drug that is potent against multiple stages of Plasmodia, with the potential to
circumvent drug resistance, and prevent relapsing malaria infection. The specific goal of this project is to
conduct lead optimization studies to produce candidates of novel prodiginines that demonstrate enhanced oral
efficacy, safety, solubility, and metabolic/PK profiles that warrant further preclinical development, and to
investigate the propensity for drug resistance to selected drug candidates and identify the molecular target(s)
through whole genome sequencing and analysis.

Public health relevance
PROJECT NARRATIVE Malaria remains one of the major world public health problems, causing about 200 million clinical cases annually and claims nearly half a million lives, mostly children under the age of five and pregnant women. Both treating and preventing the malaria infection with novel drugs that kill the parasite in new ways is highly desirable and challenging. This project investigates a natural product inspired novel antimalarial prodiginine chemotype that is potent across the parasite life cycle with potential to prevent relapsing infections and possible novel mode(s) of action.